Outer and Inner Hair Cell Development

Project Summary
The developing mammalian cochlea generates two types of mechanosensors: Inner hair cells (IHCs), endowed
with a prominent presynaptic apparatus, transmit sound information to neurons and the brain; outer hair cells
(OHCs), equipped for electromotility, are used for amplification and sharp frequency discrimination of sounds.
Loss of OHCs is the leading cause of hearing loss, and hence their regeneration could be the most valuable
means to restore hearing. In the first cycle of this grant, we found that the zinc-finger protein INSM1, expressed
in nascent OHCs, acts during a brief critical period of their early development to consolidate their fate,
preventing OHCs from transdifferentiating into IHCs. In the absence of INSM1, OHCs are born properly
specified but, within a couple of days, nearly half of them cease expressing OHC markers and proceed to
transdifferentiate into IHCs. We hypothesize that INSM1 consolidates the fate of OHCs by modifying their
epigenome, closing regulatory elements required for IHC differentiation. To test this and alternative
hypotheses, we will perform ATAC-seq on developing OHCs with and without INSM1 (which are susceptible to
transdifferentiate into IHCs) as well as in IHCs ectopically expressing INSM1. In the previous funding cycle, we
also found that the distribution of transdifferentiated hair cells varies in a graded fashion along the neural to
abneural axis, suggesting that INSM1 normally consolidates the OHC fate by preventing their responding to an
IHC-inducing morphogen. In order to identify such a morphogen, which presumably determines the IHC vs
OHC distribution in the cochlea, we will culture mutant organs of Corti and alter their extent of
transdifferentiation with agonists and antagonists of candidate morphogens and their signaling pathways.
These studies use the transdifferentiation of OHCs into IHCs as a novel means for elucidating the molecular
mechanisms (chromatin modifications, morphogens, and resulting gene expression) by which the
complementary IHCs and OHCs are generated in the developing cochlea. Finally, in the previous funding cycle
we identified an OHC-specific transcriptions factor, BCL11b which, together with its paralog BCL11a, is
necessary for the precise alignment of OHCs in parallel rows and with stereocilia pointing perpendicular to the
reticular lamina, essential features for their function as cochlear amplifiers. We will explore how BCL11b+a
achieve this task by genetic, anatomical, physiological, transcriptomic and epigenomic examinations, the same
approaches we are or already have successfully employed with INSM1. We predict that the studies here
proposed will provide an unprecedented advance in understanding how OHCs form, and align themselves, so
as to serve their role in hearing.

Public health relevance
Project Narrative Hearing loss is largely irreversible because in most cases it involves the loss of cochlear hair cells, which in mammals are for the most part not generated past embryogenesis. As OHCs are much more vulnerable than IHCs, their loss due to age, noise or ototoxic drugs is the main cause of hearing loss, and hence the regeneration of OHCs will be most often needed to restore hearing. Our discovery of the central roles played by transcription factors INSM1, BCL11b and BCL11a in OHC development provides unique and novel means for elucidating how OHCs are generated and aligned, a knowledge that will guide and assist future therapeutic attempts via regeneration.